The Role of Parents in Adolescent Obesity Treatment: Randomized Controlled Trial of TEENS+

PROJECT SUMMARY
There is an urgent need for innovative approaches to adolescent obesity treatment, particularly among African
Americans (AA), a population at increased risk of obesity and its associated morbidity and mortality. There is a
particular dearth of research on the long-term efficacy of adolescent obesity treatments. Further, research and
clinical practice guidelines consistently recommend that parents should be included in their adolescents'
obesity treatment, yet the most effective strategy to engage parents in adolescent obesity treatment remains
unclear. Towards that end, this investigation, (informed by R21HD084930), will conduct a fully-powered,
randomized controlled trial, to examine the efficacy of two distinct approaches to involving parents in their
adolescents' obesity treatment. Participants will be 210 12-16 year old adolescents (BMI>85th percentile) and
parents (BMI>25 kg/m2) with overweight or obesity. Families will be randomized to one of two 4-month
treatments: 1) TEENS+Parents as Coaches (PAC), engaging parents as helpers in their child's weight
management via parent skills training, or 2) TEENS+Parent Weight Loss (PWL), engaging parents in their own
behavioral weight management. All adolescents will participate in the TEENS+ protocol, which includes
nutrition education with dietary goals, supervised physical activity, and behavioral support, and integrates
motivational interviewing to enhance treatment engagement. Assessments of anthropometrics, dietary intake,
physical activity, parenting and home environment variables will be completed at 0, 2, 4, 8, and 12 months with
the primary endpoint at 12m follow-up. Results of this investigation have the potential to significantly advance
science in this area and ultimately inform clinical practice guidelines related to the role of parents in adolescent
obesity treatment.

Public health relevance
PROJECT NARRATIVE Although family-based lifestyle modification treatment programs (including a healthy diet and regular physical activity) are considered the mainstay of treatment for adolescent obesity, the most effective strategy for involving parents in their adolescent's treatment remains unclear. This research compares two distinct parent engagement strategies implemented within a behavioral adolescent obesity treatment, among racially and economically diverse families. Results of this investigation will inform understanding of the role of parents in adolescent obesity treatment, and thus has the potential to significantly inform the standard of care for family- based treatment of adolescent obesity.